Household Income and Child Development in the First Years of Life

Project Summary
This project will investigate late language emergence in the context of the ongoing Baby’s First
Years Study (BFY; “Household Income and Child Development in the First Years of Life”;
2R01HD087384). We will analyze existing data from the first four waves of follow-up
assessments. The proposed supplement will enrich our understanding of (1) the extent to which
poverty reduction decreases rates of late language emergence among low-income children; (2)
the extent to which late talking is a risk factor for subsequent language, executive function, and
brain activity outcomes among low-income preschoolers; and (3) the extent to which resting
infant brain activity predicts language emergence, and subsequent persistence vs. catch-up
among children with late language emergence. This will be the first research to estimate the
causal impact of poverty reduction on late language emergence. This work will additionally
inform parents, clinicians, public health officials and other stakeholders about the developmental
course of late talking among low-income children, and will inform policymakers on the possible
benefits of cash transfers to low-income children.

Public health relevance
Project Narrative There is no change from the Project Narrative submitted in the parent application.